INVESTIGATING THE ROLE OF THE LATERAL PREFRONTAL CORTEX IN MODULATION EMOTION

Our work demonstrates that the rhesus monkey provides an excellent model to study mechanisms underlying human anxiety and fear. In our studies with rhesus monkeys, we found stable, brain (right frontal EEG asymmetry), endocrine (increased cortisol and CRH), and behavioral (prolonged dispositional freezing) characteristics related to anxiety that we termed the anxious endophenotype. These findings are particularly relevant to understanding the development of human psychopathology, since children with extremely inhibited temperament and similar biological features are at increased risk to develop anxiety disorders. One of our most pertinent findings in the monkeys was the relation between extreme right frontal EEG activity and extreme anxiety. These findings are consistent with human studies demonstrating an association between asymmetric right prefrontal brain electrical activity and negative affect. It is likely that different aspects of the anxious endophenotype are mediated by the interactions of limbic, brain stem, and cortical regions. In previous work, we systematically investigated the role of the amygdala in mediating the anxious endophenotype. Using selective ibotenic acid lesions, we found an important role for the amygdala in mediating acute fear-related responses to novel stimuli; however the data suggested that the amygdala does not play a major role in mediating the stable biological and behavioral traits associated with the anxious endophenotype. While lateral prefrontal cortex (LPFC) has been implicated in cognitive processes such as attention, anticipation, and working memory, recent studies suggest a role for LPFC in integrating emotional and cognitive information important in directing goal-related behavior. Evidence from our, and other, laboratories supports LPFC involvement in emotion processing and points to hemispheric specialization. We believe that studies examining the role of LPFC in emotion processing will provide new and important insights into prefrontal cortical mechanisms underlying the anxious endophenotype and will provide an opportunity to integrate findings related to the cognitive functions of this region with emotion regulation. Therefore, in rhesus monkeys, we will use a variety of techniques (emotion probes, selective ibotenic acid lesions, PET imaging, and intra-cerebral site specific administration pharmacology strategies) to systematically evaluate the contributions of LPFC in emotion processing.